Core B: Functional Annotation Core

CORE B: Functional Annotation Core
ABSTRACT
The ultimate goal of the Program is to develop novel statistical methods to study cancer. One
important aspect of it is to understand the biology, or function, underlying the large amount of data
that will be analyzed. All four projects in this program will deal with large amount genetic and
protein data. Functional annotations to these datasets will be crucial for each project to properly
analyze the data and interpret the results. In the current funding period, the Core developed an
integrated annotation query system (AnnoQ, www.annoq.org) that incorporates existing external
annotation tools and resources, as well as in-house annotation infrastructure, including Peregrine
(www.peregrineproj.org), an enhancer to gene link database developed by this core. The system
allows researchers to quickly retrieve annotation data through either an interactive user interface
or a programmatic API. It is currently in beta release and is being used by many researchers
within USC.
We will continue to improve the system by focusing on data quality, system performance, and
user support. It will be our top priority to keep the annotation data up to date, and to maintain high
quality and accuracy of the data. Benchmarking studies will be designed to analyze and evaluate
the quality of the data. In additional, query software and packages using the AnnoQ system will
be developed and made available through Core C. With anticipated increase in data size and user
traffic, hardware upgrade and enhancement of internet security will become essential. Finally,
regular meetings with program members will allow us to provide proper training and ensure that
the system meets their needs.

Public health relevance
CORE B: NARATIVE The Functional Annotation Core (Core B) will continue to improve the Annotation Query (AnnoQ) system by improving the quality and performance of the system. The Core will work with the investigators in the Program to identify additional variants and annotation data to incorporate, and develop processes to perform quality control of the data. It will also develop appropriate IT strategies to ensure data integrity and security of the system, and develop additional software and packages to facilitate annotation data query. The Core has released the system to the public, and will provide training and support to the investigators within the Program and users in the research community.